Dynamics of Ligand Binding and Protein Kinase Regulation

PROJECT SUMMARY. Protein kinases are a large family of ubiquitous signaling enzymes in human cells. Their
dysregulation often underlies diseases such as cancer, making them excellent therapeutic targets. However, the
high structural and sequence conservation of the protein kinase catalytic domains has complicated the
development of specific inhibitors. Many clinically-successful kinase inhibitors achieve specificity in part by
binding only to distinct kinase conformations. While the analysis of thousands of X-ray crystal structures of
protein kinases has shown that a single kinase domain can access different active and inactive conformations,
little is known about how kinases interconvert between the conformations. The rationale of this proposal is that
a quantitative understanding of the stability of these conformations and the dynamics of their interconversion are
key to understanding kinase activity, regulation, ligand binding and drug resistance in health and disease states.
The objective of this project is to obtain a comprehensive understanding of the role of conformational dynamics
in kinase function, regulation and drug resistance through altered drug dissociation rates. This proposal is part
of a continuum of research centered around three questions:
Q1: How do regulatory domains, interacting proteins and disease-relevant mutations affect the conformational
dynamics of tyrosine kinases? Our goal is to determine how the solution dynamics of Src kinase domain
responds to these biologically important perturbations.
Q2: What are the molecular and cellular determinants of ligand-binding kinetics? We will test our computational
model for the drug binding process experimentally, both in vitro and in cells, by assessing drug affinities and
binding and dissociation kinetics. Our goal is to determine quantitative parameters for the drug binding process
and how the alteration of these parameters by mutation underlies drug resistance.
Q3: How can phenotypic clustering of inhibition data be used to reveal hidden kinase features? Our goal is to
mine kinome-wide inhibition datasets to group kinases by their inhibition phenotype, which reflects on the
evolutionary pressure and adaption that other biological functions impose on kinases.
We will use structural approaches (X-ray and NMR), cellular drug binding and activity assays, ligand binding
kinetics, protein engineering, chemical biology and diverse computational methods. A network of productive
collaborations supports this project. The impact of this project is to provide clinicians with the mechanism of
resistance mutations, medicinal chemists with kinase inhibitor pharmacodynamics and pharmacokinetics and
cell biologists with parameters to understand kinase signaling. The long-term goal is to lay the foundation for the
design of safe, effective, and sufficiently specific inhibitors of disease-associated protein kinases.

Public health relevance
Project Narrative This project is relevant to public health, because the understanding of how conformational dynamics affect the regulation, allosteric modulation, ligand binding kinetics and drug specificity of protein kinases is expected to increase understanding of disease-relevant kinase signaling pathways. The project aims to advance this fundamental knowledge.